Quantitative Methods for Neuroimaging Studies of Interventions in Aging

DESCRIPTION (provided by applicant): This proposal for an NIH Mentored Quantitative Research Career Award requests support for Dr. Yongmei Michelle Wang as she embarks on a faculty career focused on imaging studies which examine the influence of longitudinal interventions on brain structure and function, and its relationship to cognition and performance, in older adults. The application proposes a research career development plan in the field of neuroimaging, bridging engineering, statistics, and neuroscience. The plan includes two overlapping phases: 1) a didactic phase that emphasizes training, including coursework and laboratory work in the area of cognitive neuroscience, imaging, aging, and interventions to complement Dr. Wang's doctoral training in Electrical Engineering and existing experience in Statistics; and 2) a development phase that focuses on intense development of the proposed research. These two phases will be closely supervised by the mentor and advisor in the area of cognitive neuroscience, brain plasticity, biomedical imaging, aging and interventions. Neuroimaging techniques, such as magnetic resonance imaging (MRI) and functional MRI (fMRI), have been shown to be powerful for characterizing and understanding the structure and function of the human brain. There remains a need, however, for robust and efficient statistical image analysis methods due to the limitations of existing approaches. It is crucial that these analysis techniques be developed with a full understanding of the neuroimaging methods used and the relevant cognitive neuroscience. We propose to develop, implement, and validate integrated computational algorithms for reliable and sensitive analysis of brain MRI and fMRI images, with the following specific aims: 1) Develop, validate and combine novel and efficient univariate and multivariate morphometry analysis methods. 2) Develop and evaluate integrated functional hemodynamic response and connectivity study approaches. 3) Apply these methods to the MRI and fMRI data being collected from separately funded NIA project of the mentor, to examine the effects of aerobic fitness training on brain structure and function of older adults; the neuroscience hypothesis to be tested are: improvements in aerobic fitness, over the course of a 1 year intervention, will result in i) increases in gray and white matter volume and shape changes of subcortical structures of the human brain; and ii) changes in the underlying neural circuits. 4) Develop a brain image analysis toolbox implementing the above methods.

Public health relevance
PUBLIC HEALTH RELEVANCE: The development of quantitative image analysis methodology for the characterization of brain structural and functional changes caused by interventions (such as fitness) on the aging brain is of tremendous importance to understanding the effects of interventions on brain, and to the design of interventions that optimize the effects on cognition and brain health. PROJECT NARRATIVE The development of quantitative image analysis methodology for the characterization of brain structural and functional changes caused by interventions (such as fitness) on the aging brain is of tremendous importance to understanding the effects of interventions on brain, and to the design of interventions that optimize the effects on cognition and brain health. __SpecificAimsTextDelimiter__ RESEARCH PLAN A. Specific Aims The need for maintaining cognitive health, a vital part of healthy aging and quality of life, is emerging. A clearly delineated public health role comes at a critical time, given the dramatic aging of the U.S. population, scientific advancements in the study of risk behaviors (e.g., lack of physical activity) related to cognitive decline, and the growing awareness of the significant health, social and economic burdens associated with cognitive decline. To date, research on the aging mind is sufficiently well-developed so that it is possible to develop a blueprint for behaviors that aging Americans may engage in to maintain cognitive health. For example, participation in physical activity has been associated with the reduction of a number of physical and cognitive deficits across the adult lifespan. Physical activity, and aerobic fitness training in particular, can have a positive effect on multiple aspects of brain and cognition. Despite the wealth of knowledge that has been obtained concerning the effects of interventions on brain and cognition, there is still plenty of unchartered territory when it comes to mapping out ways that will help us keep our minds healthy, and thriving into late adulthood. The question of what conditions and interventions maintain or increase cognitive health with age is to be answered. Neuroimaging techniques, such as magnetic resonance imaging (MRI) and functional MRI (fMRI), have been shown to be powerful for understanding the structure and function of the human brain. The development of quantitative image analysis methodology for the characterization of brain structural and functional changes caused by interventions (such as fitness training) on the aging brain is of tremendous importance to further understanding the effects of interventions on brain, and to the design of interventions that optimize the effects on cognition and brain health. Maintaining a healthy mind has become a problem of increasing social urgency. Despite the progress in MRI/fMRI analysis, there is a huge need for robust and sensitive analysis methods due to the limitations of existing approaches. In this research, we propose integrated image analysis and statistical methods for discovery of structural and functional imaging biomarkers of changes in brain that are related to intervention based improvements in cognition and performance. The specific aims of the project are: ¿ Aim 1: Develop and validate new structural MRI (sMRI) brain image analysis methods. Sub-aim 1.1: Develop and validate new and efficient hybrid permutation approaches, which will be employed in group-wise comparisons based on the univariate voxel-based morphometry (whole brain analysis) and surface-based shape analysis (subcortical regions of interest (ROI) analysis). This permutation methodology takes advantage of nonparametric permutation tests and a parametric Pearson distribution approximation for significantly improved efficiency, accuracy and flexibility. Sub-aim 1.2: Develop and validate novel machine learning methods with a tensor representation, which will be used in multivariate brain image analysis, and provide an alternative way to analyze group differences and discover imaging biomarkers of the brain; these methods will accept tensors as inputs to handle the high-dimension and small sample size problem in multivariate analysis. ¿ Aim 2: Develop and validate novel fMRI brain image analysis methods. Sub-aim 2.1: Develop and validate a spatial Bayesian method for simultaneous hemodynamic response estimation and activation detection through Bayesian variable selection. Hemodynamic response functions (HRFs) at different voxels are estimated nonparametrically; activation map is generated from the full spectrum of posterior inference via a Markov chain Monte Carlo scheme. By integrating HRFs estimation and activation detection, our method is more robust to noise and less sensitive to model mis-specification. Sub-aim 2.2: Develop and validate a general statistical framework for robust and more complete estimation of brain functional connectivity based on correlation analyses and hypothesis testing. In addition to the ability of examining the correlations with each individual seed as in the standard and existing methods, the proposed framework can detect functional interactions by simultaneously examining multi-seed correlations via multiple correlation coefficients. Aim 3: Apply these novel image analysis methods to one type of intervention study, fitness training effects on human brain structure and function. The MRI and fMRI data, from a sample of 140 sedentary but healthy older adults and 35 younger adults collected or to be collected from separately funded NIA Merit Award to the mentor (Prof. Kramer), to examine the effects of aerobic fitness training on brain structure and function. We expect that i) the sensitivity and specificity of the imaging biomarkers derived from sMR and fMRI images will be significantly improved by the new technologies; and ii) combined use of the proposed univariate and multivariate analyses, and that of the proposed functional studies will outperform either one of the methods alone, i.e. each provides an important adjunct to the other. We will test the following clinical hypotheses: 1) (i.e. Sub-aim 3.1) Improvements in aerobic fitness, over the course of a 1 year intervention, will result in i) increases in gray and white matter volume in regions of the human brain (i.e. primarily frontal, medial temporal and parietal) that have previously been demonstrated to show sparing in cross-sectional and small longitudinal studies; and ii) shape changes of subcortical structures of the human brain (i.e. hippocampi, ventricles, etc.) that are related to memory, attention, and aging. 2) (i.e. Sub-aim 3.2) The improvements in cognitive processes engendered by enhanced aerobic fitness will be supported by changes in underlying neural circuits, as inferred from patterns of fMRI activation obtained in a 3 Tesla scanner. This includes changes in i) the hemodynamic response functions, and ii) the default mode and attentional networks, as well as their relationship. We hypothesize that the changes in the hemodynamic response functions, and these networks and the strength of the negative correlation between these two types of networks that result from improvements in aerobic fitness will approach those patterns exhibited by young adults. In order to test the above clinical hypotheses, in Sec. C, we provide examples of some preliminary analyses from several subsets of the aging and intervention data using either our methods or existing techniques, as the bases of the proposed clinical applications. Structural MRI (sMRI, High-resolution MPRAGE images): i) experiments comparing young and older adults shows gray and white matter volume change, primarily located in prefrontal and temporal cortices - those same regions that are often reported to show substantial age-related deterioration; ii) experiments on older adults demonstrates that individuals with higher levels of aerobic fitness display greater volume of hippocampus and better spatial memory performance than individuals with lower fitness levels. Functional MRI (fMRI) under different tasks: i) modified Stroop Task: provides manipulation of conflict level to examine differential recruitment of brain regions for attentional control in both young and old participants; ii) Dual Task: requires executive control and is used to study brain plasticity associated with executive functions due to training; iii) Passive Viewing Tasks: provides robust localization of the default mode network brain regions and allows examination of neural response patterns in the functionally defined ROIs during the relational memory paradigm, facilitating studying association between aerobic fitness, functional connectivity and cognitive performance. Aim 4: Develop a brain image analysis toolbox implementing the above methods, and share the toolbox and the developed techniques to the neuroimaging community. There is, to our knowledge, no existing tool that has the advantages (efficient or accurate or robust, etc.) of the proposed approaches. Our toolbox will implement such tools in addition to the new algorithms involved. This research will significantly enhance existing available methodology in neuroimaging.